Biological role and pharmacology of EXPERA family proteins and their effect onsterol homeostasis

Abstract
EXPERA are a family of membrane proteins that include sigma-2 receptor and TM6SF2, both of which play
crucial yet understudied roles in cholesterol metabolism and disease. Sigma-2, an enigmatic membrane receptor
implicated in cancer, Alzheimer’s disease, and neuropathic pain, has attracted significant pharmacological
interest due to its ability to bind a multitude of structurally diverse compounds with high affinity. Despite this
therapeutic potential, the gene coding for sigma-2 remained unknown for decades until I cloned it from tissue
and identified it as the ER membrane protein TMEM97. Subsequently, I solved the crystal structures of sigma-2
in complex with high-affinity ligands and discovered dozens of novel ligands through virtual docking. However,
sigma-2's precise biological function remains unclear. It interacts with key proteins involved in sterol trafficking,
such as Niemann-Pick type C1 (NPC1) and the low-density lipoprotein receptor (LDLR), but the regulatory
mechanisms driving these interactions are poorly understood. Sigma-2’s dynamic ability to shift between different
protein interaction networks in response to ligand binding or sterol stress offers promising therapeutic potential,
though the molecular events behind these effects remain to be elucidated. TM6SF2, another member of the
EXPERA family, is a regulator of lipid metabolism, particularly in the secretion of very-low-density lipoprotein
(VLDL). Mutations in TM6SF2 are strongly associated with Metabolic Dysfunction-Associated Steatotic Liver
Disease (MASLD), formerly known as NAFLD, which is a leading cause of chronic liver disease. Despite its
potential as a therapeutic target, TM6SF2 remains largely understudied, with no known ligands and limited
structural information. Understanding TM6SF2’s role in lipid homeostasis and discovering ligands that modulate
its function is critical for developing therapeutic interventions. Building on my previous success in cloning and
solving the structure of the sigma-2 receptor, my research aims to address these significant knowledge gaps.
We will use structural biology techniques to characterize the complexes that sigma-2 forms with key cholesterol
homeostasis proteins, such as NPC1. Additionally, we will investigate sigma-2’s protein interaction network and
how it shifts in response to ligands and stress conditions. These studies will improve our understanding of sigma-
2’s role in cholesterol homeostasis and inform the development of targeted therapies. Simultaneously, we will
conduct structural and functional studies of TM6SF2 to discover novel ligands and clarify its role in lipid
metabolism. By establishing ligand-binding assays and utilizing virtual docking, we aim to uncover new druggable
mechanisms for treating MASLD and related metabolic disorders. Overall, this research will advance our
molecular understanding of sigma-2 and TM6SF2, two promising therapeutic targets. By elucidating their roles
in cholesterol and lipid regulation, we aim to better understand these critical physiological processes, and to
leverage this knowledge to develop new strategies for treating cancer, Alzheimer’s disease, MASLD, and
cardiovascular diseases, addressing significant unmet clinical needs.

Public health relevance
Project Narrative EXPERA is a family of membrane proteins that includes the sigma-2 receptor and TM6SF2, two understudied regulators of cholesterol homeostasis and lipid metabolism, implicated in conditions such as cancer, Alzheimer’s disease, and metabolic disorders. This research aims to elucidate their biological functions, interaction networks, and ligands that modulate their activity, providing deeper insights into their regulation. A molecular understanding of these proteins could pave the way for significant breakthroughs in therapeutic strategies across a range of diseases.